Adaptation and implementation of a web-based Family centered Adolescent Sperm banking decision Tool for adolescent males with cancer

PROJECT SUMMARY
Advances in childhood cancer therapies have resulted in >80% five-year survival rates.1 With nearly 500,000
childhood cancer survivors in the U.S., there is a growing need to address and mitigate late effects of
treatment.2,3 Fertility impairment occurs in about half of male childhood cancer survivors and can negatively
impact quality of life.4,5 Sperm banking is an established and widely available form of fertility preservation.6
Despite recognizing the value of future parenthood and guidelines to bank sperm before treatment,6,7 banking
remains underutilized among male adolescents with cancer, especially at hospitals with low resources.8-10
Studies show adolescent males are more likely to bank sperm prior to cancer treatment if: 1) their institution
has dedicated fertility services,11 2) their provider recommends banking,12 and 3) their parents recommend it.13
To improve equitable care and access to sperm banking opportunities,10 family-centered decision tools, and
strategies to implement these tools, are critical. Our team developed the Family-centered Adolescent Sperm
banking Tool (FAST) and tested it prospectively among families of adolescent males newly diagnosed with
cancer. We found the FAST prompted deeper thinking and facilitated family communication about parenthood
goals and banking,17 and that sperm banking rates increased significantly.19 Given feasibility and equity
considerations (i.e., short time frame, variety of settings in which fertility counseling is delivered), the objective
of this proposal is to adapt the FAST to a web-based tool that can be accessed in inpatient/outpatient/non-
clinical settings, identify implementation strategies for high and low-resourced settings, and test these in a
three-site pilot study among 110 families of adolescent males (13-21 years of age) newly diagnosed with
cancer. Specific aims are to: 1) adapt the FAST (design and delivery) based on patient and caregiver
stakeholder feedback (usability testing), which will result in a web-based tool that is functional, acceptable to
families, and feasible to implement pre-cancer treatment; 2) conduct rapid contextual inquiry using a mixed-
methods approach with clinician stakeholders, to identify tailored implementation strategies for the web-based
FAST in both high and low-resourced pediatric cancer centers, prepare for adoption into clinical pathways, and
ensure fidelity and sustainability, and 3) pilot the web-based FAST and tailored implementation strategies
locally and at 2 additional sites (1 high and 1 low-resourced) to examine feasibility, acceptability, and impact on
banking rates (pre-/post design) to prepare for a larger multi-site hybrid implementation-effectiveness trial.
Findings will result in an innovative decision tool that can be easily accessed on the web and implemented at a
wide variety of high and low-resourced settings to facilitate banking decisions among adolescent males with
cancer. These efforts will optimize long-term outcomes by expanding opportunities for parenthood and
contributing to improved quality of life in a growing population of survivors, including underserved populations.

Public health relevance
Project Narrative/Public Health Relevance Statement: This research is highly relevant to public health because infertility is a significant problem in a growing population of male childhood cancer survivors. Adapting a web-based sperm banking decision tool to increase usability and acceptability and identifying tailored implementation strategies to ensure feasibility and equity, will improve reproductive outcomes and enhance quality of life. This is relevant to the part of NIH’s mission that pertains to developing fundamental knowledge that will extend human life and help to reduce the burdens of illness and disability, and specifically NCI’s mission to reduce the burden of cancer morbidity and mortality.